Gatekeeping glycan metabolism in the human gut microbiome

The overall goal of this application is to define mechanisms of glycan metabolism by bacteria inhabiting the
human gut microbiome so as to establish novel therapeutic pathways to manipulating the composition of the gut
microbial community to treat myriad human diseases. The gut microbiota has a profound effect on human health
and physiology, providing the host benefits such as modulation of immune development, inhibition of pathogen
colonization, digestion of dietary fibers and absorption of nutrients. Abnormalities in microbiota composition, or
dysbiosis, however, have been implicated in numerous and diverse disease states. A critical variable that
dictates the composition and physiology of the microbiota is the influx of glycans into the intestine, mostly from
diet and host mucosal secretions. Given the broad diversity of glycans that enter and exist in the gut,
microorganisms must possess varied and efficient strategies for competing for these nutrients, on which they
depend as a critical energy source. Despite the prominence of glycans in the human intestine and its documented
role in controlling important aspects of health and disease, the molecular mechanisms of glycan breakdown and
import employed by gut microbes remain poorly understood. This severely limits our ability to build an intellectual
framework for the design of methods and molecules with which to remodel the composition of the gut microbiota
in order to improve human health – for instance, to favor commensal over pathogenic bacteria or to limit the
growth of inflammatory or antibiotic-resistant bacteria. Here, we propose mechanistic studies using biochemical,
biophysical and genetic techniques to define pathways employed by gut microbes for the degradation and import
of various glycans, and to determine the structures and functions of key enzymes that release glycans, as well
as their interactions and functional cooperation with proteins that capture these released glycans. This work is
significant because it addresses molecular mechanisms involved in the major human health burden of dysbiosis.
The proposed studies are innovative both technically and conceptually – from the development and employment
of novel mass spectrometry-based methods for measuring the specificity and kinetics of protein deglycosylation
to the hypotheses that a single bacterium can express multiple enzymes with the same glycan specificity in order
to survive in distinct environments and that glycan-hydrolyzing enzymes have evolved to become a new class of
cell surface glycan-binding proteins. The research plan will be accomplished through ongoing and new
collaborations between the Sundberg, Koval and Mallagaray labs, who bring non-overlapping, complementary
and synergistic strengths in structural glycobiology and super-resolution microscopy, resulting in a collaborative
team ideally suited to this project.

Public health relevance
The gut microbiota has a profound effect on human health and physiology, providing benefits to the host such as modulation of immune development, inhibition of pathogen colonization, digestion of dietary fibers and absorption of nutrients, while abnormalities in microbiota composition, or dysbiosis, have been implicated in numerous and diverse disease states. Microorganisms possess varied and efficient strategies for competing for nutrients in the human gut, on which they depend as a critical energy source, the molecular mechanisms of which remain poorly understood and are the focus of the studies proposed here. Our research will allow us to build an intellectual framework for the design of methods and molecules with which to remodel the composition of the gut microbiota in order to improve human health.